Regulation of B cell Responses in SLE and Other Autoimmune Diseases

Autoimmune disease represents a significant health problem. Over the decade, novel immune based therapies
to treat autoimmune diseases, such as those used in systemic lupus erythematosus (SLE) have met
considerable efficacy challenges. This suggests that there is considerable heterogeneity in the disease, which
could occur at the genetic level, but also at the epigenetic level. Epigenetic processes, which include DNA
methylation and posttranslational modification of histones, act on chromatin structure, regulating gene specific
programs, the phenotypes, and potential actions of cells. Transcriptional and epigenetic analyses of multiple B
cell subsets of patients with highly active disease displayed a cell-type specific multifactorial signature that was
surprisingly present in naïve resting B cells (rN). The latter suggests that rN cells in SLE patients are primed to
respond to autoimmune signals. While these findings presented the bases to begin to dissect SLE related
pathways, further analyses of the same rN B cells in patients in remission/inactive disease showed substantial
heterogeneity from each other and to the active disease signature. The full heterogeneity and epigenetic
components of this signature are not yet known, and their definition may influence future care. Included within
the inactive rN signature is an increase in anergic B cells, which are reduced in active SLE. The epigenetic
programming of anergic B cells is also not fully understood in humans. To understand the heterogeneity in
patients in remission and determine the programming of these cells, in Aim 1 we will apply a comprehensive
single cell sequencing approach that utilizes barcoded cell surface markers, transcriptome analysis inclusive of
VDJ repertoire, and chromatin accessibility. Type I interferons (IFN) are an important mediator of SLE, and
cellular responses to IFN are present in all SLE molecular signatures. Anifrolumab, an IFN receptor inhibitor, is
now used in the clinics with some success as is the BAFF inhibitor Belimumab, which impacts B cell maturation
and naïve B cell survival. Because IFN and BAFF impact a number of pathways leading to autoimmunity, it is
important to know if the B cells following these treatments have reset their epigenetic features to that of a healthy
state. To answer this question, Aim 2 will focus on analyzing the transcriptomes and epigenomes of rN B cells
in patients pre and post therapy with these biologics and compare them to healthy controls. To accomplish this,
we have developed a robust experimental platform that utilizes small cell numbers for RNA, chromatin
accessibility, and DNA methylation; and have optimized CUT&Tag for histone modifications from sorted cells.
Together, these technologies will define the genes and pathways, as well as the transcription factor networks
that control cell phenotypes and the efficacy of treatment regimens to allow resetting of the epigenome to a
healthy state. We will dovetail our technologies with the Principal Project and because our technologies and
approaches are universal, this program is ideally suited for partnerships across the ACE network and
collaborative agenda.

Public health relevance
Project Narrative Not required for this component.